Role of vimentin in mammalian cell motility

ABSTRACT
Cell migration is essential to many fundamental processes, including embryonic development, wound repair,
and cancer metastasis. Central to this process is the cellular cytoskeleton comprised of three polymeric
networks: F-actin, microtubules, and intermediate filaments (IFs). Vimentin is an IF protein that is essential to
the mechanical resilience of cells and regulates cross-talk amongst the cytoskeleton, but its role in how cells
squeeze through small pores in tissues is poorly understood. We have shown that loss of vimentin enhances
cell motility through three-dimensional 3D micro-fluidic channels and protects the nucleus from damage during
migration. Vimentin is thought to play a distinct role in the transfer of forces from cell surface matrix adhesions
to the nuclear surface, but new evidence suggests that vimentin may also play a more active role in persistent
cell motility via its interactions with actin stress fiber formation and microtubule positioning. Still, the specific
mechanisms by which vimentin enables 3D migration through dense tissue remains unclear. This project
addresses the overarching question: how does vimentin influence cytoskeletal functions, adhesions with
the extracellular matrix, and cell-cell interactions to coordinate 3D cell migration? To address this
question, we will pursue three sub-projects. First, we will determine the effects of vimentin in cytoskeletal-
mediated 3D cell motility. Second, we will identify vimentin’s role in integrin expression and focal adhesion
activation, and third, we will identify the mechanisms by which vimentin mediates collective cell migration
through extracellular matrix networks. These studies will be conducted in both 2D and 3D settings to define
how changes in the cellular environment impact the critical determinants of cytoskeletal polymers in cell
motility. We expected that these projects will determine new functional roles of vimentin in cell migration, which
has important implications for understanding healthy tissue maintenance and diseases that progress by the
migration of cells through tissues.

Public health relevance
Project Narrative Cell motility is a fundamental process that contributes to building and maintaining tissues as well as diseases such as cancer. This project will determine new mechanisms underlying how cells move through three-dimensional spaces and the role of vimentin intermediate filaments in this process. This study will broaden our understanding of how cells move in physiologically-relevant conditions and its implications for human health and disease.